From Academia to Business: Development of Novel Therapeutics Against HPV-Associated Cancer

ABSTRACT
“High-risk” human papillomavirus (HPV) types such as 16 (HPV-16) are identified in the majority of HPV-associated pre-malignant and malignant pathologies of cervical, anogenital, and oropharyngeal epithelia. The
E6 protein is essential for viral replication. Structure-based computational screening followed by design and
synthesis of derivatives led to the identification of a series of small molecules that bind to the HPV-16 E6
protein and inhibits its association with the E6AP ubiquitin ligase in vitro as well as E6-mediated p53
degradation in cells. Using iterative cycles of structure based drug design and rigorous biochemical assays,
Kovina Therapeutics’ academic collaborators have identified more potent E6 inhibitory compounds. Kovina
has an exclusive worldwide license to these discoveries. The objective of this STTR application is to
characterize the pharmacokinetic properties of these unique E6 inhibitors and identify the best candidates for
advancement as therapeutics. Specific inhibition of growth of HPV-16 xenograft tumors will serve as proof of
concept validation for our lead candidates. We are ideally positioned to perform and complete requisite
pharmacokinetic, pharmacologic and toxicologic studies in the SBIR phase, leading to IND-enabling selection
of a clinical lead. Having developed and executed the experiments described in this project, the PI, Dr. Anne
Rietz, is superbly suited to continue these investigations. She will be mentored by senior leaders from
academia and the drug industry. Kovina’s CEO and Board Chair, who have successfully grown and managed
two biotech companies that were acquired, will also mentor Dr. Rietz. Along with other mentoring venues and
business school courses, Dr. Rietz will transition to a career in corporate drug development.

Public health relevance
Human papillomaviruses (HPV) encode proteins that can cause abnormal growth of infected cells. Kovina Therapeutics has licensed and is further developing drug-like compounds that block the function of a specific viral protein and inhibit growth of HPV cancer cells. Using sophisticated and powerful multidisciplinary approaches, our team will characterize these inhibitors in order to begin human clinical trials.